Enhancing Cancer Care Of Rural Dwellers Through Telehealth and Engagement (ENCORE)

The proposed project is submitted in response to RFA-CA-18-026, providing an “IT-enabled, team-based care
delivery models … to deliver comprehensive, coordinated, high-quality cancer-related care to rural low-income
and/or underserved populations.” There are widening mortality disparities among rural cancer patients,
particularly those who live in counties with persistent poverty, making it critical to develop interventions to improve
outcomes for these patients. Therefore, the proposed study is based at seven rural hospitals in Tennessee and
Mississippi, states with large rural populations encompassing a third and a half of the population, respectively.
With barriers at the health system, provider and patient level, multi-level remotely-delivered interventions that
enable rural patients and providers to access expertise housed at a comprehensive cancer center hold
tremendous promise. Through the proposed study, we will employ a Type 1 Hybrid Effectiveness-Implementation
design, which includes a traditional clinical effectiveness trial along with a process evaluation of the intervention
delivery and implementation. Specifically, we will evaluate the 1) clinical effectiveness of a multi-level telehealthbased
intervention for rural hospitals consisting of provider-level access to a molecular tumor board and patientlevel
access to supportive care; and 2) facilitators and barriers to future larger scale dissemination and
implementation of this multilevel intervention, designed to enhance quality of rural cancer care delivery. The
intervention consists of non-randomized provider-level access to a tumor board which incorporates disease,
patient and molecular tumor characteristics to enhance treatment options, together with randomized patient-level
access to a self-management intervention versus attention control. The Consolidated Framework for
Implementation Research will be used to identify barriers and facilitators. These efforts are possible due to
existing community partnerships already in place, which will be leveraged to bring comprehensive care available
at our cancer center to rural cancer patients and providers through telehealth. To further underscore the
importance of our efforts, the Southern United States in which our academic cancer center is based has amongst
the highest cancer mortality rates, and is the region of focus for this application. Our short-term goals are to
explore means by which to enhance cancer care among rural cancer patients through broadly and remotely
sharing expertise available at our cancer center with rural underserved communities in our region. Our long-term
goals are to disseminate evidence-based strategies to improve outcomes among rural cancer patients.

Public health relevance
PUBLIC HEALTH STATEMENT The goal of this proposal is to improve delivery of comprehensive cancer care delivery to rural communities with persistent poverty, where cancer incidence and mortality are high. Using the Consolidated Framework for Implementation Research, we will test a multi-level telehealth-based intervention that offers oncologists access to a Vanderbilt-Ingram Cancer Center-based molecular tumor board to expand treatment options, and offers their patients a supportive care intervention to help manage cancer therapy. This type of study is needed to develop evidence-based strategies to remotely make comprehensive cancer care available to rural patients residing in counties with persistent poverty to ultimately reduce the disparities in outcomes.